Administrative Core

SUMMARY, ADMINISTRATION CORE
CORE A, CORE LEAD: ALAN TALL
Cardiovascular disease, including atherosclerosis, is a major cause of morbidity and mortality in the United
States and around the world. The overall application, “Cellular and Molecular Mechanisms of Atherosclerosis,”
seeks to investigate mechanisms of plaque stabilization and destabilization focused on novel functions of
vascular macrophages and stromal cells, and their crosstalk, in mouse models and human cardiovascular
diseases (CVD). The overarching theme is that inflammation and the efferocytosis-resolution cycle in
macrophages regulates plaque stability through crosstalk with other macrophages and stromal cells and that
detailed examination of the cell and molecular mechanisms may provide opportunities for novel CVD treatments,
including in patients with clonal hematopoiesis, an emerging CVD risk factor.
The overall program contains three highly integrated Projects, two Scientific Cores, one Administrative Core
(Core A), and two subcontracts to Dr. Jinjun Shi at Brigham and Women’s Hospital (Projects 2 and 3). Core A
administers the overall PPG, and is responsible for the following services: A) centralized administrative actions
such as organizing productive scientific meetings; B) centralized financial record-keeping, including a monthly
report of expenditures for all program projects and cores, and all interactions with University Accounting and
Grants offices concerning grant budgets; C) preparing scientific and financial reports as required by the NHLBI
and Columbia; D) ensuring the highest level of PPG research through periodic internal and external advisory
committee review (twice and once per year, respectively); E) facilitating integration and harmonization among
program projects, including the use of shared resources, protocols, and joint experiments; and F) compliance
with all regulatory requirements, including for vertebrate animal research and human subjects research. Taken
together, the administrative services provided by Core A will yield efficient and optimal use of budget resources;
ensure regulatory compliance and the highest standards of ethical research, particularly research involving
vertebrate animals or human subjects; and enable productive, responsive, regularly-scheduled communication
and discussion among the PPG researchers, Project Leads, and Core Leads to help assess research progress
and carry out the overall Program.